Development and Application of T1rho Dispersion Imaging of Aging Muscle

Summary / Abstract
This supplement aims to extend the goals and impact of research being undertaken by award
#1K25AG076864-01 “Development and Application of T1rho Dispersion Imaging of Aging Muscle” to quantify
degenerative changes in brain tissues associated with the progression of Alzheimer’s Disease (AD). The aims
of our current parent grant are to adapt and validate magnetic resonance imaging (MRI) methods that exploit
novel contrast mechanisms based on variations of R1ρ (R1ρ =1/T1ρ -the rotating frame spin-lattice relaxation
rates) with changing the locking field frequencies, which provide new ways to detect changes in tissue, quantify
intrinsic micro-structural features such as vascular spacing, and improve the ability to discriminate pathological
processes. This supplement will specifically be used to quantify and validate changes in microvasculature and
molecular composition associated with degenerative changes in brain tissues associated with the onset of
dementia using animal models. To achieve these goals, we validate the interpretation of MRI parameters in
terms of pathophysiological changes via gold-standard methods, including histology and imaging mass
spectroscopy. The adapted T1ρ sequence and conventional MRI measurements also will be evaluated in a
large cohort of older adults (+60 years), including patients with mild cognitive impairment (MCI), AD, and age-
matched controls using a clinical 3T MR scanner. Clinical diagnosis and cognitive behavioral tests will be used
to determine the cognitive level of each participant. We predict that application of this MRI protocol will
characterize the changes in composition and microvasculature that accompany the progression towards AD in
correlation with cognitive index scores, with special relevance to changes in white matter.
Relevance to AD: The insights provided by these studies will provide new ways to extract information on
tissue composition and microstructure using R1ρ weighted acquisitions with specific applications in AD. The
supplement would support the extension of an exciting and highly innovative method of quantifying changes in
brain structure and microvasculature in aging brains and provide new, quantitative biomarkers of the changes
that occur during cognitive decline and the onset of Alzheimer’s Disease and transition to dementia.

Public health relevance
Narrative This supplement aims to extend the goals and impact of research being undertaken with award #1K25AG076864-01 “Development and Application of T1rho Dispersion Imaging of Aging Muscle”, and is submitted in response to the Notice of Special Interest NOT-AG-22-025 to “expand existing awards that are not currently focused on Alzheimer’s disease and its related dementias (AD/ADRD), to allow the research to develop such a focus.” The studies proposed will adapt, validate, and apply new ways to extract information on tissue composition and microvasculature using novel MRI acquisitions, and evaluate their value in characterizing the changes in the brain that accompany cognitive impairment and predicting the progression toward dementia.